NATIONAL RISK FACTOR SURVEY ON OSTEOPOROSIS

This is a multicentered study evaluating the influence of nutritional, reproductive, exercise and other lifestyle factors (assessed using a computer-generated questionnaire) on peak bone density measured using dual-x-ray absorptimetry of the spine, femur, and forearm in women between the ages of 20 and 40.